Resisting food temptation: how do affective and cognitive brain systems interact?

PROJECT SUMMARY/ABSTRACT
The brain's reward system can promote survival by incentivizing adaptive behaviors such as eating, or it can
undermine survival by incentivizing maladaptive behaviors such as compulsive drug use or excessive eating.
Results from animal models indicate that reward-seeking behaviors such as eating and substance use are
regulated by two systems: an affective system, which automatically allocates attention to reward-related cues,
and a cognitive system, which enables top-down allocation of attention (Pitchers et al., 2018). Animals with an
overreactive affective system are prone to compulsive cue-induced eating and cue-induced drug self-
administration, whereas animals with a strong cognitive system are often able to resist these behaviors (Tunstall
& Kearns, 2015). Much like these preclinical results, our results showed that humans with enhanced affective
responses to reward-related cues are more likely to be obese (Versace et al., 2016), are more vulnerable to cue-
induced eating (Versace et al., 2018), and are more vulnerable to smoking relapse (Versace et al., 2012) than
individuals who are not highly cue-reactive (non-cue-reactive individuals). While our results demonstrate that an
overreactive affective system confers vulnerability to many maladaptive, cue-induced behaviors, these results
are silent about the role that the brain's cognitive system plays in mitigating this vulnerability. The proposed
research aims to address the following gap in knowledge: are cue-reactive individuals also burdened by an
impaired cognitive control system, or do they have an efficient cognitive control system that is overwhelmed in
the presence of enhanced incentive responses to cues? My central hypothesis is that cue-reactive individuals
do not have a general deficit in cognitive control, but rather their enhanced cue-induced incentive responses
overwhelm their cognitive control system. I will test this hypothesis with the following specific aims: 1)
Determine the extent to which cognitive control differs between cue-reactive and non-cue-reactive
individuals while they engage affective and cognitive brain systems; 2) Integrate measures of cognitive
control into predictive models of cue-induced behavior. I will test aim 1 by monitoring the engagement of
cognitive control using power in the EEG theta frequency band—a validated measure of cognitive control—while
human subjects complete a cued food delivery task and a flanker task. To achieve aim 2, I will incorporate
psychophysiological measures of cognitive control into our predictive models of cue-induced behavior which
previously relied on affective measures only. This research is significant because it will identify not only the
mechanisms that make some individuals vulnerable to cue-induced, addictive behaviors, but also the
mechanisms that make others resilient. Furthermore, this fellowship will provide me with the necessary training
to become an impactful independent researcher in the neuroscience of addiction.

Public health relevance
PROJECT NARRATIVE The present study is aimed at identifying how the brain's affective and cognitive systems regulate cue-induced compulsive behaviors that are common to many addictive disorders. This project is relevant to NIDA because it will identify the mechanisms that make some individuals more vulnerable to addiction than others, thereby addressing the mission of the Division of Neuroscience and Behavior at NIDA: to identify the causes and consequences of drugs of abuse and addiction across the lifespan and to guide treatment strategies. Ultimately, this project will ameliorate the public health burden of addiction by informing clinicians of potential targets for the development of treatments that reduce the harmful behaviors associated with addictive disorders.